Acquisition of a Glacios Cryo-TEM for the Biological Sciences Imaging Resource

PROJECT SUMMARY
The Biological Science Imaging Resource (BSIR) at Florida State University is the focal point for cryogenic
electron microscopy (cryo-EM) in the state of Florida and the Southeast. No other University facility in the
region has a comparable emphasis or facilities. This application requests funds to replace an ageing
conventional transmission electron microscope (TEM) called a CM120 that was built in 1997 is no longer
supported by service contract and no longer has parts available for repair. We will replace the CM120 with a
ThermoFisher Glacios cryo-EM. The Glacios will serve two purposes: efficient specimen screening and
high-resolution data collection, especially for low molecular weight samples. The Glacios will support the
needs of 5 major users and 2 minor users. The Glacios is a 200 keV TEM with a field emission gun (FEG).
It is equipped with an autoloader that can robotically load up to 12 samples at a time. The autoloader
specimen carriers (cartridges) are compatible with the existing high-end Titan Krios at FSU making the
Glacios and ideal screening microscope. The Glacios will be equipped with a Direct Electron (DE) Apollo
electron detector. The Apollo will be the primary data collection camera for the microscope. We have the
first commercial Apollo equipped on our Titan Krios, and it has produced the highest resolution 3D
reconstruction at FSU. The Apollo is the fastest detector on the market which makes it ideal for screening.
The combination of the FEG and the Apollo make the Glacios a good data collection instrument as well as a
screening instrument. The study of frozen-hydrated specimens by electron tomography and single particle
methods is a large and growing research emphasis worldwide. The robotic capabilities of the Titan-Krios
with its ability to run state of the art automated EM software, such as Leginon, are well adapted to this need,
but ultimately, efficient utilization of the Titan Krios requires preparation of quality specimens that have been
prescreened. The Glacios will support NIH and NSF funded research of the major users which
encompasses the atomic resolution imaging of muscle filaments, which has health relevence to cardiac
muscle function; ribosome modification and CRISPR structure & function, the mechanisms of vesicle
trafficking sulfur metabolism, amyloid structural biology, and automated structure determination.

Public health relevance
Structural information is critical to the understanding the mechanisms that underlie biological processes and human diseases. Much of this information is now provided by expensive, high-end cryogenic electron microscopes, which collect millions of images of individual molecules robotically. A major bottleneck to structure determination is specimen preparation and screening to find the samples that will support high- resolution structure determination, and funds are requested for the purchase of a dual purpose screening microscope and data collection microscope.